Nevada Center of Biomedical Research Excellence in Molecular and Cellular Signal Transduction in the Cardiovascular System Equipment Supplement

Project Summary
The overall objective of our Phase I Center of Biological Research Excellence (COBRE) is to
establish the Nevada COBRE in Molecular and Cellular Signal Transduction in the Cardiovascular
System at the University of Nevada, Reno (UNR) and the UNR School of Medicine (UNR Med)
as a sustainable, thematic, interdisciplinary basic science research Center. This mission will be
accomplished by developing and utilizing state-of-the-art molecular, genetic, biophysical, and
biomedical imaging technologies. The COBRE comprises an Administration Core (Core A)
headed by the Program Director, Dr. Scott Earley, two Research Cores, and 5 Project Leaders.
Dr. Yumei Feng Earley is the Director of the Transgenic Animal Genotyping and Phenotyping
Core (TAGP, Core B) and Dr. Normand Leblanc directs the High Spatial and Temporal Resolution
Imaging Core (HSTRI; Core C), which provides the Project Leaders with access to a wide array
of state-of-the-art instruments enabling high spatial and temporal resolution imaging of cells and
tissues samples labeled with fluorescent indicators. The COBRE is submitting an application for
an Administrative Supplement in response to NOSI NOT-GM-22-017 that will enhance the
capabilities of the TAGP Core. The Specific Aim of this application is to purchase a new EchoMRI
machine. The price tag for this new system is $167,500. The EchoMRI allows for a non-invasive,
high precision examination of fat-mass, lean-mass, free-water and total body water in live animals,
a capability that the TAGP Core currently does not have currently. With the demand of who animal
cardiovascular and metabolic phenotyping, this system will provide new innovative techniques to
the Project leaders as well as the established members of the center and other UNR biomedical
investigators. As configurated, this EchoMRI has the capacity to perform precise measurement
of whole animals range from 25-500g. This system is also equipped with antenna/probe for biopsy
and tissue examination.

Public health relevance
Project Narrative The newly established Nevada Center of Biological Research Excellence (COBRE) in Molecular and Cellular Signal Transduction in the Cardiovascular System at the University of Nevada, Reno (UNR) is seeking funding to purchase a new whole animal phenotyping equipment, EchoMRI. The COBRE Center provides state-of-the-art cardiovascular phenotyping services to a wide community of junior and well-established biomedical scientists at UNR. The new system will be used by investigators to examine the body fat, lean-mass, and water composition that play a fundamental role in the development of cardiovascular diseases.